Arthroscopic Raman Monitoring of Cartilage Content for PTOA Diagnosis and Chondroregenerative Treatment Response

Arthroscopic Raman Monitoring of Cartilage Content for PTOA Diagnosis and Chondroregenerative
Treatment Response
PTOA is a common, incapacitating, chronic condition among individuals who sustain traumatic joint injuries.
Currently, even after “successful” surgical reconstruction of the trauma-induced pathoanatomy, supplemented
with chondroregenerative interventions, cartilage degeneration continues to progress. Therapies to improve
PTOA clinical outcomes are being developed, including chondroprotective disease modifying drugs that mitigate
or reverse degeneration of cartilage lesions and chondroregenerative tissue engineering platforms that better
recapitulate the composition and structure of healthy hyaline cartilage. However, the ability to assess the efficacy
of PTOA treatments that preserve and/or regenerate cartilage is burdened by a lack of standardized diagnostic
biomarkers that can objectively evaluate the efficacy of PTOA treatments. For clinical diagnostics, arthroscopic-
based macroscopic cartilage grading systems (Outerbridge, ICRS) and MRI portrayals of cartilage composition
are, at best, only moderately correlated with quantitative assessments of cartilage composition and material
properties relevant to the mechanical integrity and functional performance of the regenerate tissue. Raman
spectroscopy is an inelastic light scattering technique that reflects individual molecular vibrational bonds,
corresponding to specific biochemical building blocks of key cartilage constituents: GAG, collagen, and water.
We propose developing a comprehensive Raman platform for monitoring cartilage compositional biomarkers
over the hierarchy of model systems employed for cartilage treatment research, including: 1) a clinical Raman-
based arthroscopic probe that achieves real-time analysis of cartilage in in vivo animal studies and patient clinical
trials, and 2) a tissue-culture compatible Raman-spectroscopy-interfaced plate reader for the rapid, non-
destructive, repeated-measure analysis of live cartilage explants ex vivo. We hypothesize that derived Raman
biomarkers can predict the composition, morphology, and material properties of cartilage in response to
chondroprotective and/or chondroregenerative treatments more accurately than MRI and arthroscopic-based
macroscopic cartilage grading systems (Outerbridge, ICRS). We examine this hypothesis over the hierarchy of
PTOA therapy-development model systems including in vitro systems—Ovine cartilage explants subjected to
injury and treatment with chondroprotective drugs, engineered cartilage grafts subjected to physiologic + supra-
physiologic loading  inflammatory cytokines, and human cartilage explants from autopsy and arthroplasty
donors—and an in vivo system-- an ovine stifle joint subjected to PTOA injury, surgical repair, and drug
treatments. Through objective assessments of the efficacy of emerging cartilage therapies over the hierarchy of
R+D model systems—ex vivo, in vivo, clinical—Raman spectroscopy assessments can advance the next
generation of PTOA interventions into the clinic. The translation of Raman-based arthroscopy into a safe,
effective medical platform can be transformative for clinical practice, enabling rapid and efficient identification of
PTOA cartilage lesions and monitoring of neocartilage regeneration during routine arthroscopy.

Public health relevance
Arthroscopic Raman Monitoring of Cartilage Content for PTOA Diagnosis and Chondroregenerative Treatment Response NARRATIVE The ability to advance novel post-traumatic osteoarthritis (PTOA) treatments into the clinic that preserve and/or regenerate articular cartilage tissue is burdened by a lack of standardized diagnostic biomarkers that can objectively evaluate changes to the composition and material properties of PTOA chondral lesions and neocartilage repair tissue. Here we develop a novel Raman arthroscopic diagnostic platform to “optically biopsy” cartilage for quantification of biomarkers for determining its composition, structure, and material properties in health and disease. Raman monitoring of cartilage can provide: 1) objective assessments of the efficacy of current and emerging cartilage therapies over the hierarchy of R+D cartilage model systems—ex vivo tissue explants, in vivo animal studies, clinical trials—thus advancing the next generation of PTOA interventions into the clinic, and 2) a safe, effective medical platform for clinical practice, enabling rapid and efficient identification of PTOA cartilage lesions and monitoring of neocartilage regeneration during routine arthroscopy.